Extending Response Modulation to Children with Callous/Unemotional Traits

7. Project Summary/Abstract Recent research investigating childhood conduct problems (CP) has emphasized the role of examining callous/unemotional traits (CU). CU traits refer to a shallow range of emotions including low empathy, a lack of guilt or remorse, and a lack of caring about behavioral performance. Over a decade's worth of research has shown that children with CP and high levels of CU (CP/CU) differ in meaningful ways from children with CP with low levels of CU (CP-only). Although CU traits are indicative of severe CP, it is important to note that the nature of the difference is not as simple as concluding that children with CP/CU are always worse than children with CP-only. For example, children with CP/CU experience less impairment than those with CP-only in other areas of functioning including social cognition and verbal intelligence. In addition, children with CP/CU exhibit impairments unique to their condition (that are not related to CP-only) including deficits in identifying fear and sad emotions and deficits in learning from punishment. Perhaps not surprisingly then, antisocial behaviors among children with CP/CU are less strongly associated with factors related to CP (e.g., ineffective parenting; low verbal IQ). This suggests that different mechanisms underlie antisocial behaviors in children with CP such that a unique mechanism may underlie antisocial behaviors in children with CP and high CU traits. CU-related mechanisms in childhood are an important area to examine given that CU traits indicate a severe form of childhood CP, and yet represent a gap in the literature. Filling this gap has great potential to inform assessment methods for CP and contribute to novel treatments aimed at addressing the unique impairments associated with severe antisocial behavior in these children. The current study proposes to examine a cognitive mechanism-response modulation (RM)-that is influential in understanding CU-related antisocial behavior in adults and adolescents. RM suggests that individuals with CP/CU are less able to shift their attentional focus away from information central to their immediate goal and towards information that is important yet peripheral to this goal. Because attending to peripheral information is crucial in modulating between behaviors to achieve a goal in the moment, individuals with CP/CU-who exhibit a less efficient RM process-are less able to modify their ongoing and goal-directed behaviors (including antisocial behaviors). This impaired process has direct implications for their severe antisocial behavior in the moment and their severe maladjustment over time. No research has examined RM in children with CP/CU. The primary aim of the proposed study is to examine the relationship between RM and CU in children with CP/ADHD. To address this aim, 66 children with CP/ADHD (ages 6-13) will complete a number of cognitive lab tasks that have demonstrated validity in measuring RM in adults and adolescents. The efficiency of the RM process will be assessed using CP and CU as predictors of RM. Not only will the current study inform the childhood CP/CU literature, but it will also extend the RM literature.

Public health relevance
Project Narrative The aim of the current study is to develop an understanding about the mechanisms that underlie conduct problem (CP) behaviors in a severe subgroup of children with CP-those with high levels of callous/unemotional (CU) traits-using a translational research orientation and basic science methodology with the goal of informing assessments and interventions for children with CP and high levels of CU. To do so, the current proposal will extend a well-validated and prominent CU-related mechanism-response modulation (RM)-that is influential in understanding CP behaviors in adults and adolescents with CP. Because CU traits are indicative of a severe form of CP in similar ways across children, adolescents, and adults, and because little research has examined CU-related mechanisms in children with CP, extending the RM process to children with CP and high levels of CU is an important next step in understanding children who are highly at-risk for later antisocial behavior and who do not response well to current behavioral treatments. __SpecificAimsTextDelimiter__ Research Training Plan 2. Specific Aims. Identifying factors associated with severe conduct problems (CP) has been of great empirical importance given the heterogeneity of childhood CP. Over a decade's worth of research has demonstrated that callous/unemotional traits-traits related to shallow emotional experiences like low empathy and low guilt-decrease the heterogeneity of CP in children. Importantly, CU traits are associated with more severe, varied, and persistent antisocial behaviors both within treatment settings and across developmental periods (Haas et al., 2011; Lynam, Caspi, Moffitt, Loeber, & Stouthamer-Loeber, 2007). These findings motivated the proposal to DSM-V for CU traits to be a specifier for Conduct Disorder (Frick & Moffitt, 2010). Thus, CU traits are a particularly important construct to understand in childhood, when CP behaviors may be more malleable (Hawes & Dadds, 2007). Research shows that the factors that are associated with antisocial behaviors differ depending on level of CU traits in childhood CP populations. This suggests that different mechanisms are associated with each condition (CP-only; CP/CU). However, two problems emerge when attempting to understand severe CP (as indicated by higher CU): (a) CU-related mechanisms are heavily under-studied in children, and (b) the relationship between CU-related impairment on laboratory tasks and real world maladjustment is non-existent. One CU-related mechanism that is well validated within the adult and adolescent CP/CU literatures is a less efficient response modulation (RM) process (Newman, Schmitt, & Voss, 1997; Vitale et al., 2005). No direct empirical research has tested whether this model can be extended downward to understand children with CP/CU. Despite this lack of evidence in child populations, the appropriateness of the RM model has been discussed in the childhood CP literature; some researchers assert that RM can be extended downward (Hiatt et al., 2011; MacCoon & Newman, 2006) while others debate this assertion (Blair, 2010; Frick, Cornell, Bodin et al., 2003). In the current proposal, it is hypothesized that CU traits are associated with a less efficient RM process in children with CP, and it is further hypothesized that a less efficient RM process, then, is associated with more maladjustment in children with CP. The RM process is considered to play a central role in replacing maladaptive (e.g., antisocial) goal-directed behaviors with more adaptive goal-directed behaviors in the moment. An efficient RM process relies on attentional abilities. Following neural network models of attention, individuals are able to more easily attend towards "dominant" cues, or cues that are central to their attentional focus, and are less able to attend towards "non-dominant" cues, or cues that are peripheral to or outside of their attentional focus (Lavie, 1995). Thus, shifting attention away from dominant cues and towards non-dominant cues requires effortful attention. RM theorists suggest that dominant cues are those that are central to an ongoing behavior (by definition) and thus serve to engender that behavior. Consequently, attending towards non-dominant cues is imperative for alternative goal-directed behaviors to be considered, and an efficient RM process then modulates between these alternatives to determine the most appropriate behavior to engage in (MacCoon & Newman, 2006). Therefore, attending towards and incorporating information from non-dominant cues is important for an efficient RM process, and an efficient RM process is important for modifying an ongoing behavior. Adults with CP/CU have been shown to exhibit a less efficient RM process (e.g., Newman, Schmitt, & Voss, 1997), resulting in their inability to modify a goal-directed behavior, which is considered to occur because they are "less likely to be affected by or use secondary, contextual information [i.e., non-dominant cues] when it is extraneous to their dominant response set" (Zeier et al., 2009; p. 554). That is, a less efficient RM process suggests that individuals with CP/CU attend less to non-dominant information. To address the overarching research question-which mechanisms underlie the antisocial behaviors of children with severe CP-the proposed research will examine a CU-related mechanism in children with CP that has a strong evidence base in older CP/CU populations. With the collaboration of a research team that includes prominent researchers in children with disruptive behaviors-Drs. Dan Waschbusch, Karen Derefinko, William Pelham, and Paul Frick-who can provide complementary expertise for completing the proposed research the proposed training program, I will conduct a comprehensive test of RM to determine its association with CU within a childhood CP population. The specific aims of the current proposal are: Aim I. Test if CU traits are associated with a less efficient RM process in children with CP. It is hypothesized that CU will be associated with a less efficient RM process such that: 1a. CU traits will be associated with a deficient ability to incorporate non-dominant cues into a response about dominant cues. Under conditions in which participants are asked to make judgments about dominant stimuli, a less efficient RM process will be demonstrated by responding quickly and accurately to a dominant stimulus, even when a non-dominant stimulus should interfere with responding to a dominant stimulus by suggesting a different behavioral response. This will be tested in two versions of a picture/word interference task and a modified flanker interference task. 1b. CU traits will be associated with a deficient ability to respond to non-dominant cues. Under conditions in which participants are asked to make judgments about non-dominant stimuli, a less efficient RM process will be demonstrated by responding slowly and/or inaccurately to non-dominant stimuli, especially when a dominant stimulus suggests a different behavioral response. Using a novel inaccurate cue condition within a modified flanker interference task will test this. Aim II. Test if the efficiency of the RM process, in addition to CU, is related to behavioral maladjustment in children with CP. It is hypothesized that less efficient RM will be associated higher parent- and teacher-rated antisocial behaviors and higher parent- and teacher-rated behavioral impairment.